Inducing susceptibility with a small multidrug resistance transporter from P. aeruginosa

ABSTRACT
Antibiotic resistance is a growing global health concern, due in part to the action of efflux pumps in
pathogens. One class of efflux pumps, the Small Multidrug Resistance transporters (SMRs), remove toxic
compounds from the cell with proton-coupled transport. SMRs have historically been described as antiporters,
but recent evidence demonstrates that the best-studied of the SMRs, EmrE, can perform antiport, symport,
and/or uniport based on a “free-exchange” model. This model suggests that SMRs may induce susceptibility to
some compounds rather than resistance, either through direct influx/symport or by rundown of the proton-
motive force through uncontrolled proton uniport. In either case, this is a powerful strategy as it requires an
SMR to be merely present, rather than be the primary resistance mechanism of the given bacterial population.
Additionally, as the proton-motive force (PMF) is the main energy source of other multidrug-resistance efflux
pumps, rundown of the PMF means targeting other efflux pumps, not just SMRs. Herein I propose an
investigation of the transport mechanisms of PaSMR, an EmrE homolog from the pathogen Pseudomonas
aeruginosa, hypothesizing that PaSMR may induce susceptibility, rather than resistance, to some
compounds. In Aim 1, novel substrates of PaSMR will be discovered by phenotypic microarray and validated
by growth curves. WT PaSMR and a transport-dead mutant will be compared to determine if these substrates
trigger resistance or susceptibility. In Aim 2, solid-supported membrane-based electrophysiology experiments
will reveal transport mode based on differences in transported charge with various substrate/proton gradients.
This is hypothesized to be antiport for resistance substrates, but may be symport or uniport for susceptibility
substrates. Finally, in Aim 3, solution NMR resonance assignments for PaSMR will be determined, allowing the
tracking of specific residues and binding interactions with different substrates. This will identify specific
interactions responsible for susceptibility outcomes. Overall, this proposal will shift our paradigm of transport by
uncovering how PaSMR changes transport mode in a substrate-dependent manner, and investigate inducing
susceptibility and using proton-motive force rundown as a therapeutic avenue for multidrug-resistant infections.
This training plan will develop my microbiological knowledge and techniques, understanding of public
health concerns, biophysical techniques and experimental design, and management and interpretation of large
data sets. Research will be conducted at the University of Wisconsin-Madison, a leading biochemical research
center, under the supervision of Dr. Katherine Henzler-Wildman, a renowned researcher in the field of
transport as well as a co-director of the National Magnetic Resonance Facility at Madison. Training will take
place within the Integrated Program in Biochemistry, which provides high-quality biochemical education,
training in responsible conduct of research, and professional development opportunities to prepare me to be a
future leader in infectious disease research.

Public health relevance
PROJECT NARRATIVE This project investigates PaSMR, a small multidrug resistance transporter (SMR) that effluxes compounds including antiseptics and antibiotics and is found in clinical isolates of the high-priority pathogen Pseudomonas aeruginosa. Evidence suggests that PaSMR can also transport compounds or protons into the cell, inducing susceptibility rather than resistance either through symport, drug uniport, or proton uniport, the latter of which would result in proton-motive force rundown. As the proton-motive force is a main source of energy for other multidrug resistance-related efflux pumps, inducing susceptibility through SMRs may be a viable strategy even where SMRs are not the primary resistance mechanism.